Molecular Genetic Analysis of TORC1 and TORC2 Signaling in Neuronal Maintenance

Project Summary
Mitochondrial dysfunction and protein homeostasis (proteostasis) failure are common among diverse brain disorders,
from neurodegenerative disease and stroke/traumatic brain injury to brain tumor and psychiatric diseases. It is not
clear whether these seemingly disparate pathological features are mechanistically interconnected. Mitochondria play
important roles in bioenergetics as well as other essential aspects of cellular physiology, such as calcium buffering,
intermediary metabolism, and apoptosis. Maintaining mitochondrial quality and quantity is essential for tissue
homeostasis, especially the highly energy-demanding neuromuscular tissues. Pten-induced kinase 1 (PINK1) and
Parkin (encoding an E3 ubiquitin ligase), two genes associated with familial Parkinson's disease (PD), constitute a
genetic pathway important for maintaining mitochondrial health and neuromuscular integrity. Identiﬁcation of this
pathway offers a much-needed entry point to decipher the relationship between mitochondrial dysfunction and other
pathological hallmarks of disease. Our studies in previous funding cycles revealed that PINK1/Parkin directs an
interconnected mitochondrial quality control process important for neuromuscular tissue integrity. This process
encompasses biogenesis of respiratory chain, mitochondrial ﬁssion/fusion dynamics, transport, and mitophagy, and
is regulated by mechanistic target of rapamycin complexes (mTORC1 and mTORC2). Importantly, in the last funding
cycle, we found that ribosome-associated quality control (RQC), a recently recognized protein quality control
mechanism that surveys the translating ribosomes for faulty translation products to safeguard proteostasis, is an
important player in PINK1/Parkin-directed mitochondrial homeostasis. These new ﬁndings thus provide a mechanistic
link between mitochondrial function and cellular proteostasis. We found that a highly conserved RQC factor responds
to mitochondrial stress and PINK1 dysfunction and is required for stress adaptation. Activation of this RQC factor
effectively rescued PINK1 mutant phenotypes. Moreover, our preliminary studies identiﬁed several upstream factors
that regulate the post-translational modiﬁcation (PTM) of this RQC factor. These results laid the foundation for
understanding the normal physiological function of this key RQC factor and the upstream signaling mechanisms that
regulate its activity in RQC and cellular homeostasis. We will use a powerful combination of molecular genetics,
genomics, cell biology, and biochemistry approaches, and move between in vivo ﬂy models, mouse models, and
human iPSC-derived cell culture models to seek common mechanisms. We will test the hypothesis that this RQC
factor directs the quality control of the translation of mitochondrial outer membrane-associated cytosolic mRNAs to
promote mitochondria and neuromuscular tissue homeostasis under stress, and that it provides a signaling node for
integrating diverse upstream regulatory inputs to ensure the efﬁciency and ﬁdelity of this translation process.

Public health relevance
Project Narrative Mitochondrial dysfunction and protein homeostasis (proteostasis) failure are pathological features commonly associated with neurological disorders, but the mechanism behind this association is poorly understood. We have discovered that a key factor involved in ribosome-associated quality control mechanistically links mitochondrial dysfunction with proteostasis failure. By studying the mechanism, function, and regulation of this newly discovered process, this project will generate new knowledge on the pathogenesis of neurodegenerative diseases and help develop novel strategies to treat these devastating diseases.